Multi-institutional validation of a multi-modal machine learning algorithm to predict and reduce acute care during cancer therapy

PROJECT ABSTRACT
An estimated 650,000 patients with cancer receive systemic therapy or radiation therapy (RT) annually in the
United States. Many of these patients undergoing outpatient cancer therapy will require acute care with an
emergency department visit or hospital admission due to symptoms from treatment, disease, or comorbidities.
This can impact cancer outcomes, patient treatment decisions, and costs to patients and the healthcare
system. While there has been much enthusiasm for artificial intelligence and machine learning (ML) to improve
healthcare delivery, high quality prospective data are lacking, especially across diverse clinical practice
settings.
We previously completed one of the first randomized controlled studies in healthcare ML, demonstrating that
ML based on EHR data can accurately generate personalized predictions and guide supportive interventions to
decrease acute care requirements and costs in patients undergoing RT and chemoradiotherapy (CRT)
(NCT04277650). We have also developed a ML model for predicting hospitalizations based on prospective
clinical trials of daily step counts collected in patients undergoing CRT. The research objective of this
application is to leverage a geographically, racially, socioeconomically, and technically diverse network of
healthcare settings and patients to assess and maximize how accurately and equitably these approaches
generalize. Our team includes the University of California, San Francisco (UCSF), Duke University, Beth Israel
Deaconess Medical Center, Essentia Health in Duluth, MN and Ashland, WI, Washington Hospital in Fremont,
CA, Duke Regional Hospital in Durham, NC, and Duke Raleigh Hospital in Raleigh, NC. Specifically, we seek
to: (1) prospectively evaluate the validity of an EHR-based acute care prediction ML algorithm across our
network and establish a framework for equity, generalizability, and portability and (2) validate our existing
patient-generated health data (PGHD; step count) models that predict hospitalization during CRT at a second
institution and integrate with our EHR-based ML algorithm to enhance prediction of acute care needs. We
hypothesize that our approaches will be accurate across institutions though require adjustments for both
generalizability and fairness, and that EHR- and PGHD-based approaches will offer complementary predictive
performance.
The long-term goal is to develop informatics-based tools that can be broadly and equitably deployed to
improve the delivery of cancer care and subsequent treatment outcomes. This research will generate data
regarding the generalizability and fairness of EHR- and PGHD-based approaches and a platform for a future
multi-institutional randomized controlled trial.

Public health relevance
PROJECT NARRATIVE Patients with cancer undergoing cancer treatments such as radiation therapy or chemotherapy may require emergency department (ED) visits or hospitalization, a public health need that affects treatment outcomes, quality of life, and costs to patients and the healthcare system. We have developed artificial intelligence (AI) models using routine electronic health record data and mobile device step count data that have been demonstrated to predict and reduce ED visits and hospitalizations. The goal of this work is to assess and improve how well these approaches work across a network of diverse hospitals and make the benefits of this AI-supported care apply more broadly and ensure access and equal healthcare to all patients.